Signaling Mechanisms that Control Chromosome Segregation during Female Meiosis

Project Summary/Abstract
Meiosis is the cell division process that is essential for sexual reproduction because it creates
haploid gametes from diploid precursor cells. In humans, mistakes in meiosis I (MI), the unique
chromosome segregation where homologous chromosomes separate, occur at a strikingly high
frequency in female gametes (oocytes). These mistakes can cause miscarriage or birth defects,
yet the molecular mechanisms that control MI are poorly understood. Work in our lab has been
instrumental in dissecting the cellular requirements of the Aurora protein kinases used to control
MI in mouse oocytes to understand the basic mechanisms that could go awry and cause this
phenomenon.
The Aurora protein kinase family is comprised of three members: AURKA, AURKB and AURKC.
The Aurora kinases are essential regulators of chromosome segregation in mitosis, and their
activities are required for completing MI chromosome segregation. AURKC expression is limited
to gametes and is aberrantly expressed in some cancers. Our expertise in creating and
evaluating oocyte specific AURK knockout mice has allowed us to determine why oocytes
require three Aurora kinases. In the past funding period, we identified AURKB and AURKC
functions that are distinct from one another, uncovered that the three AURKs regulate one
another and elucidated the steps in meiotic spindle assembly dependent upon AURKA. The
MIRA funding also supported a new line of inquiry where we described unique features of
meiotic midbodies during MI completion. The objective of our work is to understand why the
Aurora kinases are important for maintaining genome integrity in oocytes. To reach this
objective, in the next five years we propose to expand our scope to explore AURKA
requirements for controlling protein homeostasis processes such as localized translation and
regulation of the oocyte specific subcortical maternal complex. We will also evaluate
requirements for AURKA and AURKC in completing MI by evaluating abscission timing and
formation of a meiotic midbody structure we call a cap. Information gained from our studies will
help us fully understand how these kinases operate during MI. Importantly, our results will shed
light on how mammals make high quality gametes and why it commonly goes awry in humans
leading to aneuploidy.

Public health relevance
Meiosis is the process that generates eggs and sperm necessary for sexual reproduction. For reasons not completely understood, meiosis in females is highly error prone, leading to miscarriages or birth defects. My research goals are to understand how meiosis is regulated in eggs to shed light on why this process frequently goes awry in females.